Novel Burn Sepsis Prognostic Strategies: Deciphering Early Immune Progenitor Shifts in Burn Sepsis Development and Modulation of Host Burn Response through Angiopoietin-Tie Signaling

Recent advancements in the treatment of burn shock have improved acute survival (the first 48 hours) from
severe burn injury; however, patients still experience more than 60% mortality due to infectious complications
and sepsis. Burn injury triggers a unique and profound immune response from a combined hypovolemic,
cardiogenic, and distributive shock that can lead to multisystem organ failure and death. Full-thickness burned
skin can only be treated with surgical intervention and may require months of surgery to address. During that
time, patients are highly susceptible to infectious complications, including sepsis. There is a pressing need for
new strategies to reduce infection-related morbidity and improve overall survival after severe burn injury.
Preliminary work has identified 2 unique features seen early after burn injury that correlate with the later
development of sepsis: 1) a myeloid progenitor lineage selection; and 2) elevated angiopoietin-2 (Angpt-2). To
improve the survival of all patients with sepsis, this proposed research program aims to address the following 2
critical challenges: Challenge 1 is the need to identify distinct phenotypes of immune responses to burn shock
and their relation to the development of sepsis so that novel approaches to mitigate sepsis risk can be
developed; and Challenge 2 is the need to identify the mechanism through which elevated Angpt-2 leads to an
increased rate of sepsis development. This proposed research program will prospectively follow patients with
severe burn and will combine the identification of immune system phenotypes with mechanistic drivers of
endothelial dysfunction in order to identify sepsis earlier, better predict outcomes, and identify new
mechanisms to help modulate the host response. The first project will address Challenge 1 by answering the
translational question of whether early changes in immune progenitor lines can predict patients at risk for the
development of sepsis. Not all patients response to severe burn is the same, which may be partly due to
differences in their immune responses at the level of hematopoietic progenitor cells. The hypothesis is that an
immune phenotype with increased myeloid progenitor cells will correlate with development of sepsis. A
multiomics framework will be used to identify immune phenotypes in the peripheral blood and bone marrow for
patients who do and do not develop sepsis. The second project will address Challenge 2 by determining
whether the source of Angpt-2 is the burn injury itself or if the elevation in Angpt-2 is part of the systemic
response to the burn. The hypothesis is that burned tissue is the primary driver of Angpt-2 release. This
research program will integrate in vitro models, spatial transcriptomics, and a multiomics framework to define
how Angpt-2 increases risk of sepsis development. Together, these proposed studies will test novel methods
for diagnosing and predicting sepsis, which are critical to improving outcomes in burn survivors. The findings
from these studies are anticipated to have broader scientific and clinical implications for the treatment of sepsis
in critical illness by testing immune phenotype prognostication and by modulation of Angpt-2.

Public health relevance
PROJECT NARRATIVE Patients who sustain severe burn injury can survive the acute injury, but the clinical course is complicated by severe disturbances to the immune system and infectious complications such as sepsis, leading to high mortality. This research program aims to study adult patients with severe burns to generate novel methods for early detection of sepsis, prediction of outcomes, and to identify potential mechanistic targets for therapy. The proposed research is relevant to public health because it focuses on characterizing mechanistic drivers of infectious complications after burn injury, which may lead to novel patient-targeted therapies.